Roles of NAMPT and NAD+ in hypoxic conditioning-induced neurovascular protection in subarachnoid hemorrhage

Project Summary/Abstract
Aneurysmal subarachnoid hemorrhage (SAH) is a highly morbid condition, in large part due to secondary brain
injury from Early Brain Injury (EBI) and Delayed Cerebral Ischemia (DCI). EBI occurs 1-3 days after ictus and is
characterized by blood brain barrier breakdown, neuroinflammation, and neuronal cell death. DCI occurs 4-12
days after ictus and results from a combination of large artery vasospasm and microcirculatory deficits. Given
that EBI and DCI are caused by wide-ranging neurovascular deficits, we believe that effective SAH therapy will
require a multiplicity of protective effects to maximize the chance of efficacy. We therefore applied a powerful
protection strategy with known pleiotropic effects – Conditioning-based therapy – to experimental models of
SAH. Conditioning is a concept whereby the brain's inherent resistance to injury can be enhanced by exposure
to non-harmful stress stimuli. Previously, we showed that hypoxic conditioning initiated before SAH (Hypoxic
Preconditioning) provides robust protection against DCI in an eNOS-dependent manner. Recently, we extended
upon these results in three important ways: 1) We showed that hypoxic conditioning initiated 3h after SAH
(Hypoxic Post-Conditioning; HPostC) also produces robust neurovascular protection; 2) We showed that the
NAD+-dependent deacetylase, Sirtuin 1 (SIRT1), is a key mediator of this protection; and 3) We showed
preliminarily that Nicotinamide phosphoribosyltransferase (NAMPT) is likely a key upstream molecule driving the
neurovascular protection afforded by HPostC. NAMPT is the rate-limiting enzyme in the NAD+ salvage pathway
that converts nicotinamide (NAM) to nicotinamide mononucleotide (NMN) enabling biosynthesis of NAD+, which
is an essential co-factor of SIRT1 leading to its activation.
In the present grant, we will test our central hypothesis is that NAMPT-driven NAD+ production plays a causal
role in the neurovascular protection afforded by HPostC in SAH, and that this protection is either partially or
completely SIRT1-mediated. The Specific Aims are (1) Test the hypothesis that NAMPT is necessary for the
EBI and DCI protection afforded by HPostC in SAH; (2) Test the hypothesis that therapeutic strategies designed
to augment NAMPT activity or increase NAD+ levels mimic the EBI and DCI protection afforded by HPostC in
SAH; and if so, determine if this protection is partially or completely SIRT1-mediated; and (3) Determine the
translational potential of therapeutic strategies targeting NAMPT and NAD+ by assessing their impact on long-
term cognitive deficits after SAH. Methods used include: (a) Two complementary mouse models of SAH; (b)
Assessment of NAMPT, NAD+, and SIRT1 levels; (c) Assessment of neuroinflammation, neuronal cell death,
vasospasm, microcirculatory deficits, and short- and long-term neurobehavioral deficits; (d) Pharmacologic and
genetic inhibition of NAMPT and SIRT1; and (e) Pharmacologic and genetic augmentation of NAMPT or NAD+.
Overall, the work proposed in the present grant has the potential to identify an entirely new therapies for the
treatment of patients with ruptured brain aneurysms – NAMPT activation or NAD+ augmentation. If successful,
these studies will result in an improved understanding of the breadth, mechanism, and sustainability of HPostC-
induced neurovascular protection in SAH and determine the translatability of NAMPT- and NAD+-directed
therapeutics.

Public health relevance
Project Narrative The largest treatable causes of poor outcome after brain aneurysm rupture (termed subarachnoid hemorrhage or SAH) are Early Brain Injury (EBI) and Delayed Cerebral Ischemia (DCI). In the present proposal, we plan to capitalize on the body's innate protective machinery to resist injury (a phenomenon called “conditioning”) to combat EBI and DCI. In particular, we will test two novel conditioning-based therapies (NAMPT activation and NAD+ augmentation), which if successful will establish drugs targeting NAMPT and NAD+ as new and promising treatment strategies for patients with ruptured brain aneurysms.